Examining the effect of biological sex on the tumor microenvironment and immunotherapy response

Project Summary
The parent grant focuses on the genetic determinants of distinct immune
microenvironments and response to immunotherapy. The objective focuses on determining
the genes regulating tumor composition in order to enhance tumor immunity. Similarly, this
project focuses on determining the tumor microenvironment composition between males
and females before immunotherapy a critical cofactor in all our genetic analyses.

Public health relevance
Project Narrative The objective of this application is to dissect immune mechanisms of biological sex differences in response to immunotherapy and the tumor microenvironment (TME).